Mixed Methods Evaluation of a Couples-Based Treatment to Improve CPAP Adherence and Sleep Health Among Patients with Obstructive Sleep Apnea and Increased Risk for Alzheimer's Disease

PROJECT ABSTRACT This diversity supplement is based on the parent grant (R21AG067183) “A novel couples-based sleep health intervention for older adults with obstructive sleep apnea: Implications for Alzheimer’s disease and healthy aging”. In the parent grant, we seek to develop and test a novel couples-based treatment to improve sleep health in patients with obstructive sleep apnea (OSA) and their partners. Through this supplement, we extend the development of our intervention to couples with mild cognitive impairment (MCI) and OSA. The proposed supplement continues and extends the aims of the parent grant by leveraging the existing treatment development processes and recruiting patients from existing trials of the study collaborators. It offers an ideal opportunity for training in conduct of cognitive and sleep assessments, qualitative and quantitative data collection and studies of cognitive disorders. Further, this project will advance the career development of a promising master’s degree student who has aspirations to continue to a PhD program in public health to study aging, health equity and healthcare system factors.

Public health relevance
PROJECT NARRATIVE This diversity supplement application will enhance treatment development study for couples with OSA and poor sleep quality. Results of this study will lead to greater understanding of couples- based sleep interventions for patients with sleep and cognitive disorders.